6/8: INIA Stress and Chronic Alcohol Interactions: Stress and Ethanol Self Administration in Monkeys

PROJECT SUMMARY
Chronic, heavy alcohol consumption leads to a disruption of stress homeostasis and a feed-forward cycle of
alcohol-stress interactions that further exacerbate alcohol drinking. The rhesus monkey model of alcohol self-
administration has documented allostatic changes within key brain areas associated with chronic heavy alcohol
drinking. These include hypothalamic control of the stress axis and the dorsal striatum (caudate and putamen)
implicated in control of action selection. Specifically, the striatal and HPA axis neuroadaptations were associated
with an increase in alcohol drinking during relapse, deficits in flexibility in action selection and shift in the
excitatory-to-inhibitory balance favoring the sensorimotor neurocircuitry. The proposed studies will exploit
individual differences in stress regulation and behavioral flexibility to identify mechanisms underlying excessive
drinking and susceptibility to relapse. The integrative designs encompass: self-administration with repeated
abstinence/relapse cycles in rhesus monkeys; longitudinal measures of flexibility in action selection, stress
response and integrity of brain neurocircuitry using rs-fMRI; manipulating cortico-dorsostriatal circuits in primate
brain using designer receptors exclusively activated by designer drug (DREADDs) to alter ethanol drinking,
behavioral flexibility and stress response. Ultimately, this project aims to define the role of cortico-striatal circuitry
in protecting or facilitating excessive alcohol drinking. The research will also contribute to emerging sex
differences in the stress response to chronic drinking through a balanced sex design.

Public health relevance
PROJECT NARRATIVE Many people report using alcohol to alleviate stress. Yet heavy alcohol consumption provokes a stress response, resulting in a feed-forward cycle of stress-alcohol interactions that contribute to acquiring a diagnosis of alcohol use disorders. This project uses novel neuroscience technologies in rhesus monkeys to understand how the primate brain adapts to aberrant alcohol-stress interactions and open new pathways for developing personalized treatments for alcohol use disorders.